UCLA Clinical and Translational Science Institute

The UCLA Clinical and Translational Science Institute is a research partnership of the University of California Los Angeles, Cedars-Sinai Medical Center, Charles R. Drew University of Medicine and Science and the Harbor- UCLA Medical Center/ Lundquist Institute for Biomedical Innovation. Our mission is to bring biomedical innovations to bear on the greatest health needs of Los Angeles County, which, with nearly 10 million people, is more populous than 42 states. In the past 10 years, we have built a robust research infrastructure to support our mission. In partnership with the community, we have made important advances against the leading causes of preventable disability and death. Supporting these advances is a streamlined regulatory infrastructure. We have instituted scientific review, reduced time-to-study-activation by 42%, and achieved 100% compliance with ClinicalTrials.Gov. As we enter our next decade, we will use translational science principles to accelerate the effectiveness, efficiency and engagement of our infrastructure and the research it supports. As we do so, we will build on our progress by augmenting the integration with our institutional hub partners and broadening collaborations in the community as well as with investigators outside the health professions. Through new T1-T4 seminars and team science trainings and opportunities, we will equip our trainees to conduct multidisciplinary team science across the translational spectrum. Through implementation of a systematic evaluation, we will quickly identify and address areas to improve. To achieve our mission, the UCLA CTSI has five specific aims: 1) Enhance education and training to prepare and expand the translational workforce, 2) Engage stakeholder communities in multidisciplinary team science and disseminate successful models of collaboration, 3) Integrate all populations across the lifespan into translational research, 4) Improve methods and processes to accelerate efficient, high-quality, multisite research, and 5) Provide informatics solutions to advance
high-impact translational science.

Public health relevance
With 10 million residents, Los Angeles County is the most populous in the United States. Health needs are great, as demonstrated by the rates of premature death and disability from related heart disease, diabetes, and stroke that exceed national averages. The goal of the CTSI is to bring biomedical innovations to bear on the greatest health needs of Los Angeles.